A point of care-device for the determination of creatinine phosphokinase (CPK), the CPK Now

Abstract
This application is in regard to the National Center for Advancing Translational Sciences SBIR/STTR
Omnibus Solicitation. In Vitro Diagnostic Solutions, LLC (IVDS) proposes to develop a point-of-care test (POCT)
to rapidly determine blood creatine phosphokinase (CPK) activity for the improved management of long-chain
fatty acid oxidation disorders (LCFAODs). FAODs are inborn errors of metabolism inherited in an autosomal
recessive pattern that result in deficient energy production within the mitochondria and severe downstream
effects. Infantile or adolescent-onset FAODs are associated with hepatic dysfunction, hypoketotic hypoglycemia,
encephalopathy, and intercurrent illness, with severe cases resulting in sudden death. Later or adult-onset
FAODs are typically associated with muscle weakness, myalgias, and rhabdomyolysis. The prevalence of
FAODs is about 1 in 10,000 births globally, and it is estimated that FAOD patients require 17.55 hospital days
per year comprising a significant time, cost, and effort burden on the patients, caregivers, and the healthcare
system. CPK is an important biomarker for rhabdomyolysis and metabolic decompensation and is the most
frequently monitored biomarker for patients with long-term manifestations of LCFAODs. There is an urgent,
unmet need for simple-to-use and accurate home monitoring for CPK determination to help patients manage
their hydration, diet, activity levels, and medication (Ultragenyx). IVDS has pioneered a universal POCT platform
based on a cost-effective, portable, and simple-to-use device for determining accurate concentrations of analytes
in whole blood from a finger-stick, heel-stick, or microtainer draw. The platform is based on colorimetric detection
via a reflectometer embedded with a panel of LEDs chosen to cover over 85% of colorimetric indicators currently
on the market. Test strips provide in situ separation of blood components from plasma and utilize a chemical
indicator with absorbance maximum outside the range of common interferents, e.g., hemoglobin and bilirubin, to
provide precise detection of CPK activity. The CPK Now is a single step, accurate, and rapid POCT requiring
only 20 µL of blood. A mobile app displays and stores results of blood CPK levels which can be remotely
disseminated to the care provider to make essential decisions on whether the patient should go to the emergency
room or manage from home. Successful execution of this proposal will have a lasting, positive impact on those
suffering from LCFAODs and shift the clinical paradigms surrounding recurrent rhabdomyolysis. The specific
aims of this proposal are: 1) Finalize CPK Detection Formulation, 2) Analytical Validation of Membrane
Formulations, 3) Eliminate Hematocrit Bias in the Range of 30% to 52%, 4) Establish Concordance of CPK Now
to the Reference Using Patient Samples, and 5) Prepare Final Report.

Public health relevance
Project Narrative CPK is an enzyme that is extremely elevated in cases of rhabdomyolysis, the most frequent manifestation in older children and adults with long-chain fatty acid oxidation disorders (LCFAODs). The CPK Now proposed herein will be the first remote monitoring and testing platform for real-time blood CPK activity. Such a platform will revolutionize the management of LCFAODs and recurrent rhabdomyolysis, this reducing severe health outcomes and providing personalized disease management.